STIMuLINK

Project Abstract
STIMuLINK will address Objective 2 of RFA-CE-21-002 by identifying risk/protective factors for
stimulant-involved deaths that are actionable for the development or adaptation of current prevention
and intervention efforts. For the period 2017-2024, STIMuLINK will link records from stimulant-involved fatal
overdoses found in Kentucky’s drug overdose fatality surveillance system (DOFSS) to electronic medical
records (EMR) available from the state’s largest primary and safety net healthcare system, UK Healthcare
(UKHC). This innovative data linkage reduces the surveillance bias associated with medical information
obtained only from coroner reports, makes EMR “gold standard” medical information available for research,
improves data completeness needed for risk/protective factor ascertainment using the concept of “computable
phenotypes”, and enables a comparative cohort of patients found in the EMR (i.e, those with evidence of
harmful stimulant use). Using traditional and novel (the Feasible Solution Algorithm) statistical approaches to
analyze these cohorts, STIMuLINK will examine risk/protective factors predictive of fatal stimulant overdoses
using the social ecological model as the principal framework. In parallel with these Aims, STIMuLINK tests the
use of existing biomedical natural language processing (NLP) tools to extract additional factors from the “literal
text” notes found in DOFSS (added back as structured variables to the risk/protective models when possible)
and compares findings from notes written by coroners to notes written by medical examiners in a neighboring
state. The guidance and open-source software developed from this Aim will advance the science of NLP for
automating the workflow for injury surveillance. STIMuLINK’s diverse, multidisciplinary and accomplished team
includes epidemiologists, computer scientists, lawyers, statisticians, and behavioral scientists with experience
working directly with communities impacted by the current polydrug overdose epidemic. The project specifically
includes on-going communication points with vulnerable communities and clinical populations to increase the
translational impact of the research.

Public health relevance
Project Narrative STIMuLINK provides insight on the risk and protective factors predictive of stimulant-involved deaths by unlocking the information available in the electronic medical records from prior healthcare visits and the literal text written by coroners during an overdose investigation.